Automated lung sound analysis to improve the clinical diagnosis of pulmonary tuberculosis in children

PROJECT SUMMARY
The majority of deaths from childhood tuberculosis (TB) are in children not initiated on treatment, highlighting
the urgent need to prevent delays in diagnosis. However, the diagnosis of childhood TB is challenging, as
sputum-based testing is invasive and has low yield in children, and chest X-ray (CXR) is not routinely available
in high burden settings and requires trained readers. The World Health Organization (WHO) has therefore
endorsed TB treatment decision algorithms to reduce delays in timely TB treatment initiation among children
presenting to lower-level health facilities. However, TB treatment decision algorithms have uncertain accuracy
and available data suggest they are likely to have poor specificity in the absence of CXR. Artificial-intelligence
algorithms applied to lung sounds collected using a digital stethoscope (Lung AI) have the potential to enhance
detection of lower respiratory tract disease in children being evaluated for TB. The overall objective of the
proposed project is to evaluate whether Lung AI can improve the accuracy of TB treatment decision algorithms
for childhood TB. We hypothesize that Lung AI can improve specificity while maintaining the high sensitivity of
TB treatment decision algorithms. To assess this hypothesis, we will leverage 1) existing well-characterized
cohorts to evaluate novel pediatric TB diagnostics; 2) expertise in digital stethoscopes and the development of
Lung AI algorithms for TB; and 3) experience in assessing digital health tools in high TB burden settings. In Aim
1, we will examine the accuracy of new and current TB treatment decision algorithms using existing data
collected from three ongoing childhood TB diagnostic cohorts in Uganda, South Africa, and the Gambia. At the
same time, we will prospectively enroll children with TB symptoms in Uganda, perform a complete TB evaluation
to classify TB status per NIH consensus definitions, and record lung sounds using a wireless digital stethoscope.
In Aim 2, we will use these lung sounds to train Lung AI algorithms using deep learning models to identify lower
airway abnormalities in children in reference to standardized lung sound definitions and radiology CXR reads.
We will evaluate these models in an independent test set of children with TB symptoms and healthy children. In
Aim 3, we will create a Lung AI model to detect microbiologically-confirmed or clinically-diagnosed TB in children,
and compare its accuracy to 1) the best-performing TB treatment decision algorithm, and 2) a machine learning
model that combines Lung AI and clinical variables, in the independent test set. Completion of these aims will
determine the utility of TB treatment decision algorithms, while demonstrating the potential of a simple,
affordable, digital health solution at the point-of-care to support the early diagnosis and treatment of TB and other
respiratory diseases in children at lower-level health facilities.

Public health relevance
PROJECT NARRATIVE Tuberculosis (TB) is a major cause of childhood mortality globally, and novel point-of-care tools are needed to support earlier diagnosis and rapid TB treatment initiation in lower-level health facilities. This study will develop and initially validate artificial-intelligence (AI) models that utilize lung sounds to automatically detect lower airway abnormalities and TB in children, alone and in combination with clinical data included in TB treatment decision algorithms. If successful, this would support the integration of AI-based digital health tools into clinical care to increase the early detection and treatment of TB and other respiratory diseases in children.